Evaluating the Impact of Accessible and Scalable Digital Interventions to Address Co-Occurring Insomnia and Depression in Breast Cancer Survivors Using an Adaptive Design

Project Summary/Abstract
Insomnia and depression are highly prevalent among breast cancer survivors, and the co-occurrence of these
conditions significantly increases the risk of premature death. There is robust evidence that cognitive-
behavioral therapy, which is highly scalable when delivered digitally, is effective for reducing symptoms of
insomnia and depression. SHUTi and IntelliCare are automated evidence-based digital interventions that have
individually been shown to address symptoms of insomnia and depression, respectively. However, their impact
on survivors with co-occurring symptoms of insomnia and depression have not been thoroughly evaluated.
Furthermore, it is not currently understood how multiple digital interventions could work together sequentially to
address these reinforcing conditions. This is important because providing one of these interventions alone may
not address the diverse ways insomnia and depression can manifest or their interrelatedness; while some
survivors will respond to a single intervention, others will require additional treatment to gain relief from their
co-occurring symptoms. Members of our research team previously found that in a study of breast cancer
survivors experiencing clinical levels of insomnia, SHUTi had a large effect on sleep quality. Conversely, in a
study of breast cancer survivors experiencing clinical levels of depression, IntelliCare had a strong effect on
depression. The positive results from these trials lead us to the next logical step of testing the efficacy of
SHUTi and IntelliCare against a robust control in a randomized study with long-term follow-up, as well as
developing adaptive treatments that optimally sequence these interventions to cater to the diverse needs of
breast cancer survivors. Using an innovative experimental design, called the Sequential, Multiple Assignment,
Randomized Trial (SMART), 747 breast cancer survivors with elevated symptoms of insomnia and depression
will be randomized to initially receive SHUTi, IntelliCare, or active control. We will test the impact of SHUTi and
IntelliCare on survivors’ response for their co-occurring symptoms of insomnia and depression after 9 weeks
(Aim 1). Responders are defined as those reporting clinically meaningful improvements in symptoms of both
conditions, while non-responders are those who report improvements in only one or neither condition. After 9
weeks, non-responders in the SHUTi condition will be re-randomized to either receive IntelliCare or not;
similarly, non-responders in the IntelliCare condition will be re-randomized to either receive SHUTi or not (Aim
2). This will allow us to evaluate whether added intervention improves response for survivors whose co-
occurring symptoms do not respond to a single intervention. Finally, after the trial we will match subgroups of
survivors with the treatment model that is most efficacious for them, based on their characteristics and
treatment preferences (Aim 3). This will be the first proposal to inform how to treat co-occurring insomnia and
depression among breast cancer survivors by understanding how to optimally sequence highly accessible and
scalable digital interventions that have immediate potential for public impact for serious health conditions.

Public health relevance
Project Narrative Co-occurring insomnia and depression is very common and detrimental in breast cancer survivors, and it is critical that scalable and easily accessible digital interventions are made available. SHUTi and IntelliCare are separate digital interventions that have been shown to be effective in reducing symptoms of insomnia and depression, respectively, in breast cancer survivors, suggesting strong potential for public impact, though their potential for addressing co-occurring insomnia/depression has not been tested. Using a Sequential, Multiple Assignment Randomized Trial (SMART), this proposal will evaluate the efficacy of SHUTi and IntelliCare in multiple ways: 1) as standalone interventions to reduce both symptoms of co-occurring insomnia and depression for breast cancer survivors; and 2) as components in adaptive treatment strategies that optimally sequence them for survivors who need additional treatment, resulting in a multifaceted treatment approach that is low cost, highly efficient, easily accessible, and able to cater to the unique and diverse needs of breast cancer survivors.